Revealing forces driving collective cell migration

ABSTRACT
This research program integrates concepts of biology, physics, and applied mathematics to produce
new understanding connecting cell force generation and transmission to migration. A major area of focus
is collective cell migration, which underlies essential processes in development of tissues and progression
of disease. The long-term vision of this research program is to apply experiment-informed computational
models to predict how biochemical perturbations will affect the collective migration. Such models would
enable design of methods to control the collective migration, which would lead to therapies with important
impacts on human health, such as healing of chronic wounds, slowing invasion of cancer cells, and
engineering tissues of desired size and shape.
Achieving this modeling capability requires a biophysical approach, because the motion results from
physical forces that are produced by the cells in response to biological signaling and transmitted across
the cell layer. Although there exist methods to measure the forces, the common methods used are often
uninformative for physics-based models of collective motion or for studies of the biochemical signaling that
produces the forces. Thus, there is a need to improve upon current methods and to develop new methods
to quantify forces while simultaneously connecting to both the physics-based models and the underlying
biology. The goals for this 5-year MIRA award are to advance methods in quantifying cell forces in both in
vitro and in vivo systems and to apply those methods to build frameworks that enable modeling the
relationships between biochemical signaling, forces, and motion in collective cell migration.
To accomplish these goals, the research will take two parallel approaches. One approach will improve
upon currently available experimental methods to measure forces produced by each cell, including the
variation of those forces in space and time. The other approach will develop a new methodology for
quantifying cell forces by integrating methods of data science with physics. Importantly, this new
methodology will be able to infer cell forces from only images of the cells, meaning it can be applied in
complicated cell culture systems and even in vivo. The two approaches will be used to study the collective
migration by organizing the research around two complementary frameworks: the first will study collective
motion by focusing on the forces associated with local rearrangements between neighboring cells; the
second will determine how motion is coordinated across multicellular groups. Together, these two
frameworks will provide a means to organize observations about collective migration into a holistic
understanding, which will hint at the underlying biological mechanisms and provide an essential step
forward towards achieving experiment-informed computational models that can predict the collective
migration in applications such as wound healing, cancer invasion, and tissue engineering.

Public health relevance
PROJECT NARRATIVE Collective cell migration is essential in multiple processes in human health, such as wound healing, cancer invasion, and tissue development. The proposed research will advance experimental methods for measuring cell forces and apply them in both in vitro and in vivo cell collectives. The results will form the basis for frameworks from which to organize understanding and to formulate modeling methods to predict how biochemical interventions affect the motion, which would enable numerous advances, such as new methods to accelerate wound healing, slow down cancer cell invasion, and control the size and shape of engineered tissues.